LOX-1 as a protective countermeasure in response to lung infection

Abstract
Pneumonia is a leading cause of morbidity and mortality worldwide, due in large part to the onset of acute
respiratory distress syndrome (ARDS), for which there is no greater origin. Imbalances of the biological
processes controlling immunity and tissue integrity increase the likelihood that lung infections progress to
pneumonia, demanding a better understanding of when, where, and how host signals integrate to confer
protection. Here we propose the scavenger receptor lectin-like oxidized low-density lipoprotein receptor-1
(LOX-1) as a regulatory node for shaping inflammation in the pneumonic lung. While this receptor has well-
established roles in promoting vascular injury in patients with atherosclerosis, its function in the lungs is
unknown. Our preliminary results from both mice and humans indicate substantial accumulation of LOX-1 in
pneumonic lungs. Moreover, our mouse studies reveal that LOX-1 in the airspace compartment, particularly
that originating from hematopoietic cells, dampens immunopathology in the infected lung. This contrasts the
harmful roles of LOX-1 during cardiovascular disease, implicating the alveolar milieu as a unique niche for
LOX-1-dependent tissue fortification. Although LOX-1 has never been investigated in the context of lung
infections, we posit that its expression by alveolar macrophages and neutrophils serves as a countermeasure
to dampen pneumonia-induced inflammation and maintain tissue integrity. Therefore, we will test the central
hypothesis that LOX-1 on airspace myeloid cells bolsters tissue protection in response to lung infection. This
will be addressed by pursuing the following 3 aims: Aim 1) Test the hypothesis hematopoietic cellular subsets
prominently contribute to LOX-1-driven tissue protection in the infected lung; Aim 2) Test the hypothesis that
LOX-1 promotes efferocytosis and repolarization in alveolar macrophages to limit immunopathology during
pneumonia; and Aim 3) Test the hypothesis that LOX-1 guides alveolar neutrophils towards an MDSC-like
state through altered lipid handling and anti-inflammatory feedback, countering infection-induced injury. Our
proposed studies will leverage complementary in vivo and ex vivo approaches in order to reveal basic
biological mechanisms of tissue homeostasis during pneumonia, paving the way for novel clinical interventions
in patients with or at risk for this disease.

Public health relevance
Project Narrative Lung infections are a worldwide public health crisis. They are the leading cause of acute respiratory distress syndrome (ARDS) and sepsis, and improvement in patient outcome has been virtually stagnant for decades. The goal of this proposal is to reveal the biological features of the immune receptor LOX-1 in response to respiratory infection, possibly revealing novel targets for clinical intervention in patients with or at risk for pneumonia and ARDS.